Regulation of neuronal GPCR/PKA signaling by RBM12

PROJECT SUMMARY
G protein-coupled receptors (GPCRs) shape neuronal function in response to various neuromodulators and
neurotransmitters. Conversely, dysregulation of their signaling pathways has been linked to neurological and
neurodevelopmental disorders. This highlights the physiological significance of these cascades and the pressing
need to better understand their cellular regulation. Here, we focus on RNA binding motif protein 12 (RBM12), a
novel mediator of neuronal GPCR signaling that we identified through a functional genomic screen for regulators
of the pathway. RBM12 is a poorly understood and understudied factor genetically linked to neurodevelopmental
and neuropsychiatric disorders. This proposal will build on preliminary data demonstrating that RBM12 is a
repressor of GPCR/cAMP/PKA signaling and test the central model that RBM12 is an RNA-binding protein that
regulates GPCR signaling post-transcriptionally. We will apply complementary RNA genomics, biochemistry, cell
signaling, and electrophysiology assays in human induced pluripotent stem cell-derived neurons in order to 1)
define the mechanisms governing the RBM12-dependent regulation of neuronal GPCR signaling, 2) delineate
the RBM12 sequence features that underlie the regulation and determine whether these are disrupted by
disease-associated human polymorphisms, and 3) characterize the role of the RBM12-GPCR interplay in
shaping neuronal activity. Successful completion of the studies will yield an integrated mechanistic and functional
understanding of RBM12’s role in receptor-dependent neuronal function. Additionally, our analyses could pave
the way for in vivo characterization of this interplay to establish RBM12-dependent dysregulation of GPCR/PKA
cascades as a tentative novel mechanism underlying neuronal disorders associated with rare human mutations
in that gene.

Public health relevance
PROJECT NARRATIVE Signaling by G protein-coupled receptors (GPCRs) and Protein Kinase A (PKA) is critical for brain physiology, and these cascades are often dysregulated in disease. In this project, we will define how RBM12, a recently identified risk gene for neurodevelopmental and psychiatric disorders, mediates this pathway, and how the regulation shapes neuronal functions. Given the important roles of GPCR/PKA signaling in the brain, it is anticipated that this study will yield insights of fundamental relevance to neurobiology and may illuminate the cellular basis of neurological diseases arising from rare human mutations in RBM12.